Developing a public health measure of built environment to assess risk of nonmedical opioid use and related mortality in urban and non-urban areas in New Jersey

ABSTRACT Nonmedical opioid (NMO) use (misuse of either prescription opioids or heroin) and related overdose and mortality are rapidly growing public health problems. In particular, there is quite a bit of evidence that the NMO epidemic is growing particularly rapidly outside of major city centers and urban areas (i.e., in suburban and rural areas). While there has been a great deal of empirical evidence suggesting that features of physical and social environments, taken together (i.e., using a built environment framework) represent strong predictors of drug use and mental health outcomes in urban settings, there is a dearth of research assessing the built environmental features of non-urban settings in order to predict risk for NMO outcomes. The proposed study will compile data from secondary data sources for 566 municipalities in New Jersey to address this gap. New Jersey was chosen for its epidemiological relevance and its availability of NMO overdose data. In recent years, the highest rates of NMO overdose emergency room admissions have occurred in counties comprised of suburban and rural areas. The proposed study will be the first to systematically measure physical and social environmental features, i.e., the built environments, of non-urban areas which are theoretically and empirically related to NMO use, in the service of developing a built environment framework that can estimate municipality-level risk of NMO use and overdose in non-urban settings. This study will address the following specific aims: Aim 1. 1a. To develop a measurement strategy that extends use of the built environment framework to describe features of the physical and social environments of non-urban areas which are theoretically relevant for NMO use and overdose. 1b.To construct a spatial data infrastructure of built environment data to be utilized in a Geographic Information System (GIS) with which to test the feasibility and validity of this new built environment measure among both urban and non-urban communities. Aim 2. To assess the validity of the measure produced in Aim 1 by examining its relationship to various social and environmental constructs. We will assess the predictive validity of the new measure in part by examining its ability to predict areas at higher risk for overdose at the municipality level (among both urban and non-urban areas). We will also assess correlations of the new measure with other municipality level variables in order to establish concurrent, convergent, and discriminant validity. The development of this new built environment measure and corresponding spatial data infrastructure can be replicated, thereby allowing public health departments and other service organizations to identify specific areas with greatest risk for NMO morbidity and mortality. This, in turn, will allow them to strategically allocate resources to these areas and to design and/or modify their prevention and intervention efforts to address area vulnerabilities and to more directly and efficiently target high-risk populations.

Public health relevance
Public Health Relevance Statement Despite evidence that nonmedical opioid (NMO) use (misuse of either prescription opioids or heroin) and related overdose and deaths are rapidly growing public health problems, and that the NMO epidemic is growing particularly rapidly in non-urban areas, and despite evidence that features of physical and social contextual environments are good predictors of drug use and mortality, no research has yet systematically measured features of the physical environments in non-urban areas in order to predict risk of NMO-related outcomes (i.e., use, overdose, mortality). The proposed study will be the first to develop and validate a measure of the drug use- and morality-relevant built environment (i.e., the physical and social features of a setting which are theoretically and empirically linked to drug abuse and mortality) that is designed to capture specific features of both non-urban and urban environments, and will also produce a spatial data infrastructure with which to utilize this measure within a Geographic Information System (GIS). This data and measurement system will be easily replicable and will allow local public health entities to identify communities with highest risk and vulnerability for NMO morbidity and mortality, to more strategically allocate resources and funding to these areas, and to design and/or tailor their prevention and harm reduction programs to meet the specific needs of and address the physical and social vulnerabilities of these previously understudied and underserved areas, thereby potentially improving both the efficiency and efficacy of their responses to the NMO epidemic.